MD/FAMILY PARTNERSHIP--EDUCATION IN ASTHMA MANAGEMENT

There is a critical need to improve the skills of non specialist physicians who see children with asthma. Both under treatment and lack of effective patient education by physicians are cited as reasons that asthma related problems are on the increase. The purpose of this study is to test the effectiveness of an educational intervention based on self-regulation theory in changing diagnosis and treatment patterns and educational behavior of non specialist pediatricians who treat children with asthma. It is hypothesized that education for physicians, based on the principle of self-regulation provided through an interactive seminar, will be effective in changing physicians' clinical behavior and improving their performance as health educators and counselors. We will also assess the effects of education for pediatricians on the self-management behavior, health status, and health care utilization of their patients. A true experimental design involving 52 physicians and 468 parent-child pairs from their practices will be utilized. A team of researchers from the University of Michigan and Columbia University will carry out the study in the Ann Arbor, Michigan and Metropolitan New York areas. The study is unique in that it is the first evaluation research to focus on pediatricians who treat asthma and to apply theories of self-regulation of behavior to physician education. It is one of few to use changes in patient self-management behavior and health care use as outcomes of physician education.